Neutrophil lineage in inflammation

ABSTRACT
Neutrophils constitute the first line of cellular defense against pathogenic microorganisms. In response to pro-
inflammatory cues, unrestricted neutrophil activation induces tissue damage. To avoid deleterious effects to the
host, neutrophil numbers, activation, and lifespan must be tightly regulated, but the molecular mechanisms that
control neutrophils in the context of inflammatory disease remain elusive. Cardiovascular disease is the leading
global cause of death. Recent evidence supports an important role for neutrophils in the development of coronary
artery disease (CAD). Neutrophils are present in early aortic lesions and in rupture-prone atherosclerotic
plaques, and a positive correlation between plasma levels of neutrophil secretory proteins and CAD has been
established, suggesting that neutrophil exocytosis mediates detrimental effects in CAD. Furthermore, neutrophil
production is increased in the bone marrow in atherosclerotic models and newly identified neutrophil precursors
are now known to mediate inflammation. How neutrophil subsets contribute to disease progression in CAD has
not been studied and the regulation of neutrophil diversity in disease is unknown. The inflammasome is an
emerging driver in atherosclerosis; however, the role of the NLRP3 inflammasome activation selectively in
neutrophils on atherogenesis has not been studied and the mechanisms regulating the functions of neutrophil
lineage cells in the context of inflammasome activation and atherogenesis remain unknown. In this synergistic
program, Project 1 Neutrophil Development During Inflammation and Atherosclerosis will study how neutrophil
heterogeneity is modulated in human subjects with CAD, and how the NLRP3 inflammasome in neutrophil
progenitors influences granulopoiesis and neutrophil heterogeneity in atherosclerosis. Project 2 Neutrophil
Mechanisms During Inflammation and Atherosclerosis will test the hypothesis that hyperlipidemia differentially
regulates vesicular trafficking and associated functions of neutrophil precursors in CAD, establish mechanisms
of NLRP3-induced neutrophil exocytosis dysregulation and implement translational approaches to decrease
neutrophil inflammation in CAD. Project 3 Neutrophil Survival and Demise During Inflammatory States will
characterize the expression and function of components of the NLRP3 inflammasome in cells of the neutrophil
lineage, and will define the effects of hyperlipidemia-induced inflammation and the roles of death receptor
signaling in IL-1β production, mitochondrial apoptosis in viability of neutrophil lineage cells, and necroptosis
signaling in atherogenesis. Our synergistic and unique program uses the complementary expertise of three
renown researchers, experts in the areas of neutrophil development, neutrophil intracellular function regulation
and inflammation, to study the central hypothesis that unrestricted activation of neutrophil progenitors and mature
neutrophils is a fundamental process in cardiovascular disease. These studies will lead to novel approaches to
treat neutrophil-mediated inflammation in CAD.

Public health relevance
NARRATIVE Neutrophils are blood cells that protect the body from infections, but their unregulated activation leads to disease in humans. Cardiovascular disease remains a leading cause of death worldwide but how neutrophils and their precursors contribute to the development and progression of cardiovascular disease is currently unknown. The objective of this Program is to elucidate the mechanisms regulating neutrophil-mediated inflammation in coronary artery disease and to discover new therapies to treat this devastating and common disease.